The RCMI Program in Health Disparities Research at Meharry Medical College

Project Summary/Abstract
The kidney podocytes are highly vulnerable to damage by HIV infection. This damage can be exacerbated in
podocytes that express variants of the APOL1 gene, G1 and G2, which are unique to the African population
and found in about 13% of African Americans (AAs). Notably, expression of APOL1 variants has been linked to
a higher risk of non-diabetic chronic kidney disease (CKD), faster progression to end-stage kidney disease
(ESKD), and HIV-associated nephropathy (HIVAN). The risk of developing ESKD in HIV-infected AAs is 50
times higher than in whites, and more than 70% of AAs with HIVAN have two APOL1 gene risk variants. While
antiretroviral therapy (ART) has reduced the incidence and mortality of HIVAN, certain drugs are nephrotoxic
and poorly target latent HIV reservoirs.
HIV infection in the kidney cells occurs in a low-oxygen environment (hypoxia), which stabilizes oxygen-
sensitive hypoxia inducible factor HIF-1α. HIF-1α binds to the hypoxia response element (HRE) DNA motif in
gene promoters to induce transcription of a wide range of genes. However, most studies of HIV replication
were conducted under normoxic conditions, where HIF-1α is degraded. There is evidence that hypoxia inhibits
HIV-1 replication and promotes latency by reducing HIV-1 promoter activity by epigenetic modifications, such
as promoter methylation. In this regard, the HRE elements have been identified in HIV-1 promoter sequences.
We have shown that hypoxia stimulates the expression of APOL1 RVs in urine-derived podocytes from AAs by
recruiting HIF-1α to HREs in the APOL1 promoter. This suggests that APOL1 RVs may affect the methylation
status of the HIV-1 promoter and stimulate virus replication in hypoxia. However, the molecular mechanisms
underlying this epigenetic modification of the HIV-1 promoter in the context of APOL1 RVs expression have not
been investigated. We hypothesize that the expression of APOL1 RVs in hypoxic podocytes contributes to
increased HIV-1 replication by promoting demethylation of HRE in the HIV-1 promoter. We will test our
hypothesis in two specific aims: 1) Establish the methylation status of the HRE in the HIV-1 promoter in
hypoxia in podocytes without and with APOL1 RVs and 2) Identify the mechanism(s) by which APOL1 RVs
promote HIV HRE demethylation in hypoxia. At the completion of the proposed research, we expect to define
the mechanisms by which APOL1 RVs in podocytes of AA origin promote HRE demethylation and stimulate
HIV-1 replication in hypoxia. These results may provide a link between the expression of APOL1 RVs in
hypoxia and the development of HIV-associated nephropathy and present new therapeutic targets to combat
HIV replication in AAs with APOL1 RVs.

Public health relevance
Project Narrative The kidney cells are highly vulnerable to damage by HIV infection. This damage can be exacerbated by the expression of APOL1 gene variants, which are unique to the African population and found in about 13% of African Americans. Notably, in HIV-infected individuals with APOL1 risk variants, the reduced oxygen level in the kidney stimulates both the expression of APOL1 and HIV. In our proposed research, we will establish the mechanism by which APOL1 risk variants expressed in the kidney cells stimulate HIV-1 replication in low oxygen levels.